Circuit and Molecular Anaylses of Cerebellar Output Neurons

? DESCRIPTION (provided by applicant): The goal of this project is to generate cellular and molecular information critical for improving clinical treatments of cerebellar disorders and for fundamental understanding of the mechanisms responsible for cerebellar control of oculomotor, skeletomotor, autonomic, and cerebral cortical circuits. Although much is known about cerebellar physiology, anatomy, and vulnerability to damage and disease, clinical treatments of cerebellar disorders are limited by the paucity of cellular and molecular information on cerebellar output neurons required to identify specific drug targets. The specific objectives of the project are to elucidate molecular and synaptic information in functionally distinct types of cerebellar output neurons. To achieve these objectives, quantitative, single-cell gene expression analyses of specific classes of cerebellar output neurons will be performed. Complementary anatomical circuit analyses will identify differential synaptic connectivity, and in vitro physiological experiments will probe the impact of cerebellar cortical computations on spike timing and rate in distinct classes of cerebellar output neurons. These experiments will provide a critical foundation for rational pharmacological therapies for postural instability and autonomic dysfunction and other debilitating sequelae of cerebellar disorders. Revealing the expression of neurotransmitter receptors, ion channels and other drug targets on physiologically and anatomically-defined subsets of cerebellar output neurons will enable enhanced specificity and efficacy in restoring postural and oculomotor stability, autonomic regulation, and cognitive functions while minimizing side effects

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this project is to obtain quantitative gene expression, microcircuitry, and cellular and synaptic physiological information about specific classes of cerebellar output neurons essential for mediating cerebellar influences over posture, eye movements, cardiovascular and respiratory coordination, and cortical state. The results will provide fundamental information required to guide rational pharmacological therapies that differentially target autonomic, motoric, and cognitive consequences of cerebellar dysfunction. Revealing the expression of neurotransmitter receptors, ion channels and other drug targets in physiologically and anatomically-defined subsets of cerebellar output neurons will enable enhanced specificity for restoring postural and oculomotor stability, autonomic regulation, and cognitive functions while minimizing side effects.